Hepatic stellate cells in liver homeostasis and regeneration

The long-term goal of our research is to identify pro-regenerative to improve liver regeneration. The only curative
therapy for end-stage liver disease is liver transplantation as no regenerative therapies exist. Liver
transplantation is limited by donor graft supply. Living donor transplantation or split liver transplantation, in which
one organ is split among two patients, rely on the regenerative capacity of the liver to restore its mass. The
number of these interventions has increased to gap the bridge between demand and supply but post-
hepatectomy or ‘small-for-size’ syndrome, which reflect a regenerative failure, present severe complications for
which only supportive but no regenerative therapies exist. We have identified a novel hepatic growth factor,
neurotrophin-3 (NTF3), that induces hepatocyte proliferation in culture and increases liver mass after
administration to rodents. NTF3 is a member of the nerve growth factor family, that is secreted by hepatic stellate
cells (HSC) and signals through tropomyosin kinase receptors (TRKs). While HSCs contribute to liver
fibrogenesis during injury, HSCs are known to release growth factors which may be critical during liver
regeneration. Using a novel HSC-depletion mouse model that used genetically engineered T cells to deplete
HSCs after adoptive transfer, we discovered that HSCs maintain liver zonation, hepatocyte proliferation and liver
mass. As liver regeneration occurs staggered in a zonal fashion to ensure functioning hepatocytes at any time
during the process, liver zonation is critically important for liver regeneration. Our preliminary data indicate that
HSCs and NTF3 promote liver regeneration and that NTF3-TRK signaling is relevant to humans as well. As there
are known TRK-agonists and FDA-approved TRK-antagonists, our central hypothesis is that HSCs and HSC-
derived NTF3 promote liver regeneration and that TRK-agonists improve liver regeneration. We will test our
hypothesis in three specific aims: 1. To determine if NTF3 and TRK signaling maintain liver zonation and promote
liver regeneration in rodent models of liver regeneration; 2. To establish NTF3 and TRK signaling in human liver,
primary hepatocytes and hepatic organoids; 3. To clarify NTF3-TRK downstream signaling pathways in cultured
liver cells. Our proposed studies will provide important insights into a novel hepatocyte growth signaling pathway
and generate preclinical data to assess TRK-agonists for potential regenerative therapies.

Public health relevance
Liver transplantation is the only curative option for patients with liver cirrhosis and there are no regenerative therapies available, although they are urgently needed. We identified a novel growth factor that induces proliferation of hepatocytes suggesting it improves liver regeneration. As this there are known and FDA-approved compounds to enhance or inhibit this pathway, we propose to assess if these compounds can be used to improve liver regeneration, which could eventually improve patient outcomes.